Novel animal models to study organ-specific SARS-CoV-2-induced pathology

Accumulating evidence suggest that SARS-CoV-2 infection induces tissue pathology in multiple organs in
addition to the lung, including, among others, intestine, heart, liver, kidney, and brain. Furthermore, SARS-
CoV-2 infection can exacerbate many chronic inflammatory diseases. However, mouse models that allow
to study SARS-CoV-2-induced pathology in specific organs are currently lacking. Additionally, therapeutic
strategies using the commercially available K18-hACE2 transgenic mouse model are limited due to ectopic
hACE2 expression in the brain driving high lethality. To overcome these problems, we have generated mice
with conditional tissue-specific hACE2 expression. The goal of this proposal is to characterize these novel
mouse models and define the impact of SARS-CoV-2 specifically on lung immunopathology and intestinal
disease. Our central hypothesis is that mice with conditional expression of hACE2 in Rosa26 locus
represent a robust platform to study tissue-specific SARS-CoV-2-induced pathology. In Aim 1, we will test
the hypothesis that hACE2 expression in type II alveolar epithelial cells and club cells is necessary and
sufficient for SARS-CoV-2-induced lung immunopathology. We will analyze SARS-CoV-2 infection
dynamics and lung immunopathology in mice with specific expression of hACE2 in type II alveolar epithelial
cells and club cells, using our recently developed dual reporter- expressing mCherry-Nluc recombinant
(r)SARS-CoV-2. In Aim 2, we will test the hypothesis that SARS-CoV-2 infection exacerbates intestinal
inflammation using mice with specific expression of hACE2 in intestinal epithelial cells. This proposal is
innovative and significant, as it will generate and characterize novel small animal models to study SARS-
CoV-2 mediated organ-specific disease and provide insights into mechanisms of SARS-CoV-2-mediated lung
and gut pathology. These mouse models will provide a robust platform to study and monitor SARS-CoV-2
infection in desired cell types and long-term complications of SARS-CoV-2 infection, and to perform
therapeutic interventions.

Public health relevance
Animal models of SARS-CoV-2 infections are critical for the discovery of therapeutics, as well as understanding SARS-CoV-2-induced acute respiratory distress syndrome and extra-pulmonary complications. Unfortunately, current mouse models for COVID-19 do not allow to study the mechanism of organ-specific pathology. The proposed research is critical to public health because it will generate novel preclinical mouse models to study tissue-specific SARS-CoV-2-induced disease and provide a deeper understanding of the fundamental mechanisms controlling lung and gut pathology.